Understanding Treatment Response Patterns And Therapy Resistance In IDH-Mutant AML

ABSTRACT
The discovery of IDH1 and IDH2 mutations in AML, and the accompanying functional implications of the resulting
neomorphic activity of these mutated enzymes, has resulted in FDA approved targeted therapies. Similarly, the
changes brought about in methylation due to IDH mutations in the AML genome have ushered in treatment
regimens combining venetoclax with hypomethylating agents. In this setting, where traditional chemotherapy
regimens also are applied for treatment of primary diagnoses, the available outcomes data for all three
therapeutic approaches should now provide clear metrics of predicted response, given the correct analytical
methods. However, given a lack of direct comparison studies, no guidance exists as to which treatment choice
will provide best response in IDH-mutated patients. Furthermore, emerging data about the importance of the
biologic context on the response to different agents, including co-existing gene mutations and patient age, pose
additional questions that need to be systematically addressed in order to provide patients with the best treatment.
In order to address this imminent question, and provide data-driven treatment decision support for the ~20% of
AML patients harboring IDH mutations, we are proposing a carefully designed, translational study:
To directly compare the response of IDH-directed and non-IDH directed targeted therapy, we designed the first
head-to-head comparison trial for older and unfit IDH-mutated patients. This long overdue study will provide
information about treatment response, as well as first insights into the optimal sequence of treatments, with
respect to co-existing molecular features. The trial will be complemented by correlative studies that aim to assess
the utility of clonal outgrowth tracking and residual disease assessment for possible dynamic treatment
adjustments (iDATA trial, Aim 1). Utilizing the AML patient collection from the Alliance for Clinical Trials in
Oncology, as well as our newly established multicenter collaboration between six major US Cancer Centers, we
have assembled the thus far largest cohort of 930 IDH-mutated adult AML patients, treated with standard
cytotoxic chemotherapy, hypomethylating agents or IDH-directed or non-directed targeted inhibitors. Following
our experience in genomic risk stratification models, we are equipped to identify markers predictive of treatment
response based on treatment type and genomic context (Aim 2). Lastly, to better understand resistance and
escape mechanisms to targeted and non-targeted therapies, we will leverage our large longitudinal specimen
collections provide a comprehensive molecular characterization of the leukemic clones during different disease
and treatment stages; including clonal and subclonal evolution, identification of clone-specific altered cellular
pathways and epigenetic changes at each stage (Aim 3).
We are confident that this comprehensive approach, executed by a skilled investigator team will shift current
clinical practice paradigms towards data-driven and personalized treatment approaches.

Public health relevance
NARRATIVE With the new availability of several treatment options for AML patients harboring IDH1 or IDH2 mutations, it is not known yet how to predict which therapy will lead to the best treatment response for individual patients. We will perform the first head-to head comparison trial of the sequence of therapy with IDH-directed versus non- IDH-directed small molecule inhibitors for newly diagnosed, older IDH-mutated AML patients, complemented by the analysis of the largest to-date cohort of IDH-mutated AML patients to delineate clinical and molecular predictors of treatment response to different frontline therapies, including cytotoxic chemotherapy and small molecule inhibitors, which will be complemented by the integrated analysis of our large longitudinal patient collection. We hypothesize that these data analyses will characterize therapy-associated molecular treatment response patterns, with the overarching goal to provide data-driven support for for molecular-based treatment choices that improve outcomes of IDH-mutated AML patients.